Sci-Tech Core-Maryland Population Research Center

The Scientific and Technical Core (STC) aims to provide MPRC associates with the computational resources
and technical support necessary to conduct cutting-edge population research. The STC is designed to deliver
services to faculty that are not offered by their individual units on campus, including access to secure data
enclaves for restricted and confidential datasets, hosting web sites for data dissemination and archiving, and
offering training and consultation services in statistical programming and data management. Through its
computer lab, the STC provides access to specialized software that may not be available to researchers in
their academic departments. The core also offers a platform on which to run computationally-intensive jobs.
The STC facilitates collaboration by allowing faculty associates and external affiliates to share large datasets
through a secure storage area network. In the next grant cycle, the STC anticipates expanding its support for
the use of restricted datasets for which it maintains two secure data enclaves and provides remote secure-data
computing and secure data storage services. The STC will also play a critical role in promoting the use of the
recently-established Federal Statistical Research Data Center (FSRDC) at the University of Maryland. The
FSRDC is one of the most exciting university-wide initiatives that gives researchers access to highly-restricted
social, demographic and health-related data sources, including datasets linking individuals to administrative
records. The STC will play a key role in disseminating information about the data available at the FSRDC
through three planned conferences over the next five years, and by assisting researchers in their application
for access to the restricted data. MPRC staff will also provide formal and informal programming support to
faculty associates interested in using the FSRDC. To evaluate its effectiveness in meeting faculty demands in
the next grant cycle, the STC will collect detailed information on usage of its services, and conduct surveys of
all associates every two years. The STC is directed by Andres Villarreal (Sociology), a social demographer
with extensive knowledge of statistical and computational methods.